Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY
The Administrative Core of the AK INBRE 5 network provides administrative support, fiscal analysis, and coordination of network programs and activities for the six partner institutions: University of Alaska Fairbanks, University of Alaska Southeast, University of Alaska Anchorage, two tribal health organizations, Southcentral Foundation and Alaska Native Tribal Health Consortium, and Iḷisaġvik College, a new partner in AK INBRE 5. The Administrative Core will support the AK INBRE 5 One Health research network and its goals to enhance capacity for biomedical and behavioral research and growing a pipeline of Alaskan students entering health careers in the state. The Administrative Core is a hub for communication, outreach, and program activities fostering collaboration and interactions across Alaska. AK INBRE 5 PD/PI will lead the core from UAF in collaboration with the Associate Director and Program Coordinator. The Administrative Core facilitates overall coordination and sharing of resources among all IDeA and other NIH programs, University of Alaska campuses, and other Alaska network partners with similar infrastructure and goals in Alaska. The Administrative Core will facilitate achieving the aims of the INBRE cores and programs and will organize productive meetings for committees and researchers that focus on collaboration across Alaska. The Administrative Core is also home to the Student Research Program. The Student Research Program will be led by experienced leaders in undergraduate student research mentorship and facilitation and will guide program progress in Alaska through excellent communication and transparent decision-making in coordination with applicable committees. Finally, the Administrative Core will oversee the Evaluation Plan. Internal and external evaluations will create formative and summative processes for tracking program progress and results, identify the “whys” of program component successes and challenges and identify linkages between actions and outcomes. The evaluation component is designed to change throughout the lifecycle of the proposed grant and will adapt to unpredicted program modifications and needs